Targeted Automated Nephrology e-Consultation for Diabetic Kidney Disease

ABSTRACT
Diabetic kidney disease (DKD) is an enormous and growing public health problem that is associated with
significant cardiovascular morbidity/mortality and kidney failure, in addition to posing a significant economic
burden for the US health system. Patients with DKD experience significant gaps in the delivery of guideline-
recommended treatments for reducing the risk of cardiovascular disease and kidney failure. Previously studied
interventions intended to address these gaps have relied on overburdened primary care teams and have
shown only modest success. The overall goal of the proposed research is to design and pilot an intervention of
proactive nephrology e-consultation which leverages the electronic health record to identify patients with DKD
who might benefit from nephrology expertise, but whose kidney disease is not severe enough to require in-
person nephrology referral. As part of this intervention, nephrologists would perform targeted, automated
consultations (TACos) for eligible patients by reviewing patient charts and providing individualized
recommendations focused on delivering guideline-indicated DKD care. For health systems with limited
subspecialist capacity for in-person visits, TACos offer a “high-touch” approach to extending subspecialty
expertise in collaboration with primary care to reach a broader population. For DKD, TACos have the potential
to promote both utilization of established DKD therapies and uptake of novel therapies, such as sodium-
glucose cotransporter 2 inhibitors. The specific aims of this project are 1) to conduct semi-structured interviews
of primary care clinicians and nephrologists to understand the most helpful elements of a TACo intervention; 2)
to use a microsimulation modeling approach to determine the best strategies for targeting TACos for optimizing
impact and equity based on existing practice patterns in a local setting; and 3) to evaluate the feasibility and
acceptability of a pilot implementation of TACos in one public health care delivery system.
To accomplish the goals and to prepare Dr. Chu for an independent research career as an implementation
scientist focused on improving chronic kidney disease care, he will be mentored by a team of experts in
qualitative research methods, kidney disease epidemiology, simulation modeling, and implementation science.
Specifically, this proposal will allow the Dr. Chu to achieve the following training goals: 1) undertake formal
didactic and mentored training in implementation science; 2) develop skills to design and conduct qualitative
research studies to inform intervention design; 3) learn to apply simulation modeling approaches to predict
potential impact of interventions; and 4) gain experience conducting a pilot study that implements and
evaluates a care delivery intervention. Completion of these aims will generate the preliminary data and provide
a training foundation to support an R-level proposal to study the effectiveness of TACos or other population
health approaches to improve DKD care in diverse health systems.

Public health relevance
PROJECT NARRATIVE Diabetic kidney disease is an enormous and growing public health burden, and significant gaps in guideline- recommended care delivery exist for patients with DKD. This project aims to design and pilot an intervention of targeted, proactive, electronic nephrology consultation to improve care delivery for primary care patients with diabetic kidney disease in an urban public health system, with special attention toward minimizing racial and ethnic disparities. Through this proposal, insights gained from key stakeholders across multiple health delivery systems, as well as preliminary data and implementation experience, will inform the design and implementation of larger system-scale interventions for improving care delivery for diabetic kidney disease and preventing its complications, including cardiovascular disease, kidney disease progression, and kidney failure.